Personalized Synchronization of Cortical Rhythms to Improve Memory in Alzheimer's Disease

PROJECT SUMMARY/ABSTRACT
Alzheimer’s disease is a severely debilitating disorder. It affects over 50 million people worldwide and its
associated costs are estimated to exceed $305 billion annually. By mid-century, 153 million people are
expected to be living with Alzheimer’s disease and costs are projected to surpass $1 trillion, as the global
population rapidly ages. Impaired working memory is a central feature of the cognitive deterioration in
Alzheimer’s disease and a primary driver of disability, placing sharp limits on social functioning, activities of
daily living, and quality of life. Working memory refers to our ability to hold behaviorally useful information in
mind over a period of seconds and is a fundamental building block of human cognition and the gateway to
long-term memory. Neuroscience investigations have demonstrated that working memory function is
subserved by oscillatory mechanisms in the healthy brain, and that specific patterns of synchronous oscillatory
dynamics may be important for understanding the disease mechanisms of Alzheimer’s disease, consistent with
the longstanding hypothesis of Alzheimer’s disease as a disconnection syndrome. Here, we examine the
mechanisms of working memory impairment in Alzheimer’s disease from a physiologically inspired perspective
centered on large-scale brain networks and how they interact through synchronized electrophysiological
oscillations. We focus on established neural coding schemes (i.e., cross-frequency coupling and phase
synchronization) hypothesized to index flexible large-scale circuits that integrate information across multiple
temporal and spatial scales during cognition. We combine high-density electroencephalographic
measurements of synchronized oscillations with personalized high-definition transcranial alternating-current
stimulation to determine whether it is possible to modify components of frontotemporal networks and cause
rapid improvements in working memory function. Our preliminary data are highly encouraging and indicate that
we can causally modulate the synchronization of long-range low-frequency oscillations, increase local phase-
amplitude coupling, and improve working memory capacity in people with Alzheimer’s disease to levels
equivalent to that of demographically matched healthy controls. The goals of the research program are to use
novel neuroscience tools and analytic procedures to gain a deeper understanding of the pathophysiology of
memory impairment in Alzheimer’s disease, and achieve concrete translational progress toward the
development of personalized, non-pharmacological interventions for improving memory and cognition in
Alzheimer’s disease and related dementias.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease is a severely disabling brain disorder, exacting a significant toll on those afflicted and large personal, social, economic, and public health costs. The potential contributions of this research program include elucidating the neural mechanisms of cognitive deficits in Alzheimer’s disease, and developing a personalized, non-pharmacological intervention therapy for improving cognition in Alzheimer’s disease and related dementias.